The molecular mechanisms underlying context-specific Runx factor functions in directing hematopoietic cell identity

PROPOSAL SUMMARY/ABSTRACT
My long-term career goal is to broaden our understandings of molecular and cellular mechanisms
governing hematopoietic cell fate decisions both in normal and pathogenic conditions as an independent
investigator. A central question of my research is how broadly expressed transcription factors regulate a distinct
set of genes in different developmental programs, as transcription factors’ ability to provide precisely required
functional inputs in each cellular context is essential for life-long production of healthy blood cells. To address
this, I propose to determine molecular mechanisms driving dynamic functions of Runx transcription factors in
early thymic T cell development and megakaryocyte differentiation, two vastly different programs relying on Runx
activities. Also, I aim to exploit a novel cell culture technique recapitulating the connection between bone marrow
progenitor stages and early thymic progenitor stages. This will establish a new opportunity to define the roles of
transcription factors in this developmental window, which was previously challenging due to lack of in vitro system.
My preliminary studies suggest that Runx factors possess notable ability to switch their DNA binding sites
in a context-specific fashion both within the same developmental trajectory at different stages as well as across
different cell types. These dynamic Runx binding sites are closely associated with the genes that are sensitive
to Runx functions. Importantly, redistribution of Runx factors occurs across large genomic domains and multiple
peaks appear and disappear coordinately. Also, cell type-specific Runx binding sites harbor distinct sets of other
transcription factor motifs, suggesting that a unique ensemble of collaborators may be present in each cellular
context. Thus, I hypothesize that 3D chromatin reconfiguration responds to or causes context-specific Runx
binding site choices, and these dynamic Runx functions are driven by distinct co-factors in each program.
To address this, I will determine whether developmental changes of 3D chromatin structure require or
instruct Runx functions during early T cell development (AIM 1, mentored phase). Also, I will define which
functional collaborators physically interact with Runx factors in early T cell development and megakaryocyte
development and test which co-factors are necessary to guide cell type-specific Runx DNA binding (AIM 2A).
Additionally, I will define the impact of cell type-specific partners on Runx functions independently of chromatin
state by experimentally introducing mismatched-co-factors to non-native developmental context (AIM 2B). Finally,
I will establish a novel in vitro system recapitulating the developmental transition from bone marrow progenitor
phases to early thymic progenitor stages. I will exploit this system to test whether the principles underlying
dynamic Runx functions apply to the activities of another multilineage-expressed transcription factor, c-Myb.
Together, the studies in this proposal will show how globally expressed transcription factors execute context-
specific functions in different developmental pathways in normal hematopoiesis, and how malfunction of these
principles can cause hematologic pathologies, such as leukemia.
1

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to reveal how broadly expressed gene-regulating proteins control distinct gene expression programs to shape different blood cell fate decisions by focusing on Runx proteins’ activities in early T cell development and megakaryocyte development. I aim to address my hypotheses that relationship with 3D chromatin structure and the availability of physically interacting co-factors instruct context-specific functions of Runx proteins. In addition, this proposal will test whether the principles underlying dynamic Runx activities apply to other multilineage-expressed regulators’ functions and show how these gene-regulating proteins provide precisely needed regulatory inputs to normal blood cell production but can cause hematologic pathologies when dysregulated.